Advancing cancer care and equity through telehealth, communication science, and behavioral economics

PROJECT SUMMARY/ABSTRACT (OVERALL)
The University of Pennsylvania Telehealth Research Center in Cancer Care (Penn TRC) will apply insights
from communication science and behavioral economics to design and test innovative telehealth strategies to
improve effectiveness and equity across the cancer care continuum, with an emphasis on understanding
mechanisms of action. The COVID-19 pandemic led to dramatic growth in the use of telehealth for cancer care
delivery, fostered by both clinical need and temporary waivers. Telehealth strategies have included both
synchronous communication (real-time video or telephone conferencing) and asynchronous communication
(sequential health information exchange through text messaging or secure portals). Yet, fundamental
knowledge gaps include the extent to which telehealth may be superior to non-telehealth care delivery
strategies for access, quality, and outcomes; how telehealth may enhance or detract from achieving health
equity in cancer care in the context of the digital divide and persistent cancer disparities; and the impact of
telehealth on health care efficiency. The Penn TRC will address an overarching research theme: to apply
insights from communication science and behavioral economics to design and test synchronous telehealth
strategies, supported by asynchronous elements, to improve access, quality, outcomes, equity, and efficiency
across the cancer care continuum. We focus on lung cancer as a model for telehealth across the care
continuum, from screening to treatment to survivorship. We bring together a team of international experts in
communication science, behavioral economics, cancer care delivery, telehealth, health care innovation, mixed
methods, and health equity to achieve the following specific aims: 1) Apply concepts, strategies, tools, and
methods from communication science and behavioral economics to design and test synchronous telehealth
strategies, supported by asynchronous elements, to improve access, quality, outcomes, equity, and efficiency
for patients across the care continuum; 2) Conduct a pragmatic randomized clinical trial to compare the
effectiveness of telehealth strategies to increase shared decision making for lung cancer screening using a
Sequential Multiple Assignment Randomized Trial (SMART) design; 3) Conduct two rapid-cycle pilot projects,
with methods and measures aligned with the pragmatic trial, to design and test the effectiveness of telehealth
to improve cancer care, identify multilevel mechanisms of action, and lay the foundation for future, more
definitive pragmatic trials; and 4) Build capacity to advance a national telehealth research agenda and train the
next generation of investigators with expertise in cancer care, telehealth and health equity. By joining together
interdisciplinary faculty across Penn, the Penn TRC will result in novel, scalable, and generalizable
disseminated strategies to drive lasting improvements in cancer care and health equity. Penn has an
unparalleled environment in which to bring together these areas of study.

Public health relevance
PROJECT NARRATIVE The University of Pennsylvania Telehealth Research Center in Cancer Care (Penn TRC) will apply insights from communication science and behavioral economics to design and test synchronous telehealth strategies, supported by asynchronous elements, to improve effectiveness and equity across the cancer care continuum, with an emphasis on understanding mechanisms of action. We focus on lung cancer as an exemplar model for telehealth across the care continuum, from screening to treatment to survivorship. The Penn TRC will produce new fundamental knowledge with the potential to transform cancer care delivery, equity, and outcomes for millions of Americans.